Investigator Development Core

SUMMARY- INVESTIGATOR DEVELOPMENT CORE
The Pilot Program will emphasize high quality research that promotes collaboration between the Center and
the partner communities, and promotes development of new investigators as they strive to establish
independent research programs in Native environmental health disparities research. The Pilot Program will
align with the Center’s mission and theme by providing sub-awards to partner organizations in support of
innovative research ideas of importance to environmental health disparities. The overarching objective of the
Pilot Program is to encourage active participation of Center partners to develop a sustained, powerful
influence on reducing health disparities by promoting quality research and building long-term research
capacity. We will work with community partners to identify research questions and develop research
approaches to address gaps in knowledge related to the impacts of environmental health disparities within
our partner communities. We will identify specific research questions of concern related to exposure from
burning trash, microplastics, or environmental metals. Center researchers will work directly with community
members and research partners to construct hypothesis driven research proposals that directly address
community concerns and that fit within the scope and capabilities of the Center. We will work to promote
research opportunities for young investigators and members of health disparity populations through
recruitment, mentoring, research training and professional development opportunities. We will leverage off
existing programs and Centers, take advantage of strong institutional resources and support, and build on
our existing success to recruit promising young investigators from members of health disparity populations to
our Center. We will provide mentoring support, research training and professional opportunities that will
promote successful completion of projects and promote long-term research capacity.